Hybrid Rat Diversity Program - Import of HXB/BXH panel

Project Summary
The Hybrid Rat Diversity Program (HRDP) at the Medical College of Wisconsin (MCW) is
pleased to submit this administrative supplement for support during the current grant year
(ending January 31, 2025). The overall goal of the HRDP program is to extend the use of rat
models for clinical translation through establishing an animal resource and genomic dataset to
facilitate the translation of laboratory research to clinical relevance. The HRDP parent project
has successfully established ~80% of the panel, including the entire FXLE/LEXF recombinant
inbred panel and nearly all of the classic inbred strains. The HXB/BXH recombinant inbred
panel currently has only 14 strains available to the biomedical research community due to a
limited number of embryos available, challenges associated with the BN strain contribution to
rederivation attempts, and pathogen status of a subset of embryos and strains. This supplement
application proposes to complete the HXB/BXH recombinant inbred panel through the import of
17 rat strains from the Czech Academy of Sciences in Prague to the Medical College of
Wisconsin. Living colonies of the remaining HXB/BXH strains are available from Dr. Pravenec’s
lab at the Czech Academy of Sciences. However, these strains are on the verge of elimination
due to a lack of financial support and pending retirement of Dr. Pravenec. This supplement aims
to 1) to identify healthy, pathogen free rats for each of the 17 strains, 2) prepare and ship these
rats with a tracking system to ensure successful transfer of the strains, and 3) establish colonies
of these strains using quality control measure for health status and strain identity. The most
efficient and cost-effective approach to acquire these key HRDP strains is by importing
pathogen free rats from the Czech Republic to MCW. The rat strains and associated genomic
and phenotypic data will be made available to the research community.

Public health relevance
Project Narrative This supplement to the HRDP R24 resource grant aims to make the HXB/BXH recombinant inbred panel available to the research community through successful import of the rat strains from the Czech Republic to the US. This project will ensure that these models are pathogen free and available for use by investigators. Through the parent award, these models whole genome sequencing and broad phenotypic characterization will be publicly available.